Impact of a Novel Socially Assistive Robotic Architecture on Engaging Older Adults with Mild Cognitive Impairment, Alzheimer's Disease, and Related Dementia in Long Term Care Settings

Project Summary/Abstract
This is an administrative supplement to a currently awarded study, Impact of a Novel Socially Assistive Robotic
Architecture on Engaging Older Adults with Mild Cognitive Impairment, Alzheimer’s Disease, and Related
Dementia in Long Term Care Settings (R01AG062685). Apathy is common in persons with AD and ADRD with
prevalence rates up to 72%. It is associated with further cognitive decline, functional deficits, reduced quality of
life, social isolation, and increased mortality. Apathy imposes significant burden on LTC staff and negatively
impact quality of care, staff satisfaction and turnover. Since few pharmacologic options exist, a major strategy is
to foster older adults’ engagement in social, physical and cognitive activities, primarily those that are multimodal
in nature. However, these interventions often require significant personnel time and resources, a major concern
given the current nursing shortage and high turnover among LTC nursing personnel. The Centers of Medicare
and Medicaid Services mandates LTC facilities to provide meaningful engaging activities for residents, which
can be resource intensive and are difficult for many US LTC settings. The currently awarded study focuses on
the use of an intelligent socially assistive robot (SAR) based architecture, called ARIA (Adaptive Robot-mediated
Intervention Architecture), as an approach to engage older adult residents suffering from apathy. This
interdisciplinary proposal is directly aligned with the NIA goals of understanding and developing effective
interventions using smart technology to reduce the burden of age-related diseases and address the special
caregiver needs of those caring for persons with dementia (PWD). This multi-phase, multi-site, mixed methods
clinical trial will systematically examine responsiveness and engagement among persons with MCI or dementia
to two types of SARs (humanoid and animal), its effect on cognitive, physical and social function as well as the
impact of SARs on informal and formal caregivers with a goal towards future scalability and sustainability. The
specific aims of the proposed research are to compare the effect of usual care (UC) group to UC+ARIA group
on reducing apathy among older adults with mild cognitive impairment (MCI), mild dementia, or moderate
dementia and to identify barriers and facilitators to SAR implementation across sites to address future scalability
and sustainability. This study will contribute to the development of improved intelligent technology as an effective
approach to engage older PWD with the long term goal of enhancing function and quality of life. This
administrative supplement application is in response to the unforeseen and unavoidable consequences of the
COVID-19 pandemic on long term care settings that has resulted in significant delays in study deployment,
increased time and effort for long term care site recruitment, and increased time and effort in conducting the
study from originally conceived. The supplement would allow us to intensify our recruiting efforts thereby meeting
the enrollment goals of the parent grant.

Public health relevance
Project Narrative As an increasing number of older adults are suffering from Mild Cognitive Impairment (MCI), Alzheimer’s disease (AD) and AD-related dementias (ADRD); providing them with quality care in long term care (LTC) facilities is becoming problematic due to resource limitations, nursing shortage and high turnover among LTC nursing personnel. A novel approach to utilize socially assistive robotic systems that can meaningfully engage this group of older adults through physical, cognitive and social activities is proposed in the hope that such smart technology will be able to augment, and not replace, the current system of care. This study will contribute to the development of improved intelligent technology as an effective approach to engage older persons with dementia with the long- term goal of enhancing their function and quality of life as well as improving LTC staff satisfaction.